Structural correlates of protection for antibodies targeting Marburg virus GP2

PROJECT SUMMARY
Marburg viruses are highly lethal human pathogens with unpredictable patterns of emergence that have led to
over 15 human outbreaks since their discovery in 1967, with average case fatality rates of ~50%. The natural
target of neutralizing and protective antibodies in Marburg virus infection is the membrane-anchored surface
glycoprotein (GP), but only four sites on Marburg virus GP have been identified as protective targets for such
antibodies. As such, and in contrast to the numerous antibodies identified against the related Ebola viruses, the
repertoire of effective monoclonal antibodies (mAbs) against Marburg viruses is severely limited in size and
functional diversity, and no mAb countermeasures are currently approved for clinical use. Of the four known sites
of vulnerability on Marburg virus GP one falls within the N-terminus of the GP2 subunit, referred to as the “wing”,
that is targeted by protective but non-neutralizing antibodies. Such antibodies have been isolated both from a
human survivor of infection and from animal immunizations. Limited structural information is currently available
on the GP2 wing and its recognition by antibodies, which has hampered efforts to define underlying molecular
determinants and correlates of protection for this region. We previously immunized a Rhesus macaque with
repeated doses of diverse Marburg virus GP antigens and isolated a new panel of cross-Marburg virus GP-
reactive monoclonal antibodies. Within this panel, we identified three antibody lineages, CM10, CM11, and
CM12, that target the GP2 wing. Here, we will undertake in-depth biophysical and functional analyses of the
CM10, CM11, and CM12 lineages, including assessment of binding affinities to GP, capacity to mediate Fc
effector functions, and capacity to potentiate virus neutralization by receptor-binding region antibodies (Aim 1).
To determine the structural basis for CM10, CM11, and CM12 recognition of the GP2 wing and to delineate
structural correlates of protection, we will undertake a combined electron microscopic and crystallographic
approach to determine their structures in complex with GP ectodomains and GP2 wing peptides, respectively
(Aim 2). A selected subset of variants for will be tested for protective efficacy in a hamster model of Marburg
Angola virus infection and disease under ABSL-4 containment (Aim 3), which will enable subsequent association
with functional and structural attributes. Taken together, our proposed studies will advance the understanding of
the GP2 wing as a target for protective mAbs and will expand the repertoire of candidate immunotherapeutics
against Marburg viruses.

Public health relevance
NARRATIVE The repertoire of protective antibodies against Marburg viruses is limited in size and functional scope, with only four known sites on the Marburg virus surface glycoprotein (GP) identified as targets for such antibodies. The GP2 wing represents one such target, but structural and functional determinants that confer antibody-mediated protection through this region remain to be fully elucidated. Through a newly discovered set of antibodies that target the GP2 wing, we undertake combined structural, functional, and animal efficacy studies to establish correlates of protection and expand the repertoire of candidate antibody countermeasures against these lethal viruses.